Equipment Supplement_Govind_1R15GM148919-01

PROJECT SUMMARY
The Summary remains unchanged from the original proposal.

Public health relevance
PROJECT NARRATIVE The Narrative remains unchanged from the original proposal.